Multiscale modeling and empirical studies of normal and pathological brain aging

Project Summary/Abstract
Progressive myelin dystrophy, loss of synapses, and neuronal hyperexcitability are hallmark changes in the
neocortex common to both normal aging and early-stage sporadic Alzheimer’s Disease (AD), a disease of aging.
The precise relationships of these changes and how they drive age- and AD-related cognitive impairments
remain elusive. In the rhesus monkey, a species unaffected by clinical AD, these sub-lethal age-related changes
in the dorsolateral prefrontal cortex (dlPFC) correlate with degree of working memory (WM) impairment. Given
that myelin dystrophy is an early and profound phenotype, it is likely that long-range heavily myelinated axons
or those that have high myelin turnover may be most vulnerable. In monkey dlPFC, layer 3 (L3) pyramidal cells
(PCs) extend horizontally oriented axon collaterals from the main axon to form periodically spaced columnar
axonal plexus clusters. These clusters are implicated in sustained neuronal activity during WM and are the
anatomical expression of interconnected L3 PCs forming excitatory reverberating circuits modulated by local
inhibitory inputs. The parent L3 PC axons project to three targets: local intrinsic targets within the same cluster,
long-range intrinsic targets in adjacent clusters, and long-range extrinsic targets in other cortical areas. Our
preliminary data suggest that these target-specific axons differ with regard to their structural features including
degree of myelination. We hypothesize that heavily myelinated axons/collaterals and their downstream targets
are more vulnerable to the effects of normal and pathological aging than are lightly myelinated or unmyelinated
axons/collaterals and this underlies specific WM dysfunction. Further, we hypothesize that remyelination of
affected fibers is capable of rescuing neuron and circuit function in computational models. The organizational
features of dlPFC circuits provide a rigorous framework for modeling and empirical validation across many spatial
and temporal scales. Aim 1 will model the effects of selective myelin loss and its contribution to/interaction with
hyperexcitability on action potential conduction of parent axons and their local and long-range collaterals, and
how these changes impact synaptic communication in small circuits of neurons analogous to the clusters and
gaps seen in dlPFC. Aim 2 will employ large-scale models of WM to answer the important question of how
progressive changes in myelin, synaptic connections and neuronal excitability interact to effect WM and how the
addition of neuron loss further impacts network function. Both Aims 1 and 2 will test the effect of variable and
site specific remyelination on model function. Aim 3 will use quantitative anatomical and physiological approaches in
rhesus monkey dlPFC across the adult lifespan to provide validation of model predictions and also help constrain
models in an iterative manner. Results will be invaluable for the future development of biophysically realistic
computational models of WM that incorporate multiple brain areas, layers, and cell types in the context of normal
aging and AD. These insights, combined with precise techniques to perturb and rehabilitate neurons and
networks, are essential for the development of therapeutics for cognitive decline in normal aging and in AD.

Public health relevance
Project Narrative Working memory mediated by the prefrontal cortex is among the first cognitive abilities to decline in both normal aging and early-stage sporadic Alzheimer’s Disease (AD); importantly, both conditions also share features such as progressive myelin dystrophy, loss of synapses, and neuronal hyperexcitability in the prefrontal cortex. The precise relationships of these changes and how they drive age- and AD-related working memory decline remain elusive and will be studied with multi-scale computational models of neurons, axons, synapses, local circuits, and large-scale models of working memory in Aims 1 & 2 that will be constrained and validated by state-of-the- art anatomical and physiological approaches in Aim 3. Insights from this project, combined with precise techniques to perturb and rehabilitate neurons and networks, will contribute to the targeted development of therapeutics for cognitive decline in normal aging and in AD.